Implementation of Overdose Prevention Practices in Permanent Supportive Housing

PROJECT SUMMARY
Permanent supportive housing (PSH), the gold standard intervention for ending chronic homelessness, has
expanded rapidly across the U.S. in recent years and is likely to continue expanding as homelessness
increases in the wake of the COVID-19 pandemic. Due to a confluence of individual and environmental risk
factors, PSH tenants face heightened risk for overdose (OD). While evidence-based practices (EBPs) to
prevent OD exist, they have not been broadly implemented in PSH settings. We propose to address this
significant research to practice gap by tailoring a set of evidence-based OD prevention practices for PSH
settings, then studying their implementation in 20 PSH buildings in New York. We will test a package of
implementation strategies that includes an implementation toolkit, tenant-staff implementation champion dyads,
limited practice facilitation, and learning collaboratives. The project will be conducted in partnership with the
Corporation for Supportive Housing, a national organization that advances solutions to improve PSH through
education, practice, and policy. Aim 1 is to adapt evidence-based OD prevention practices for PSH, using key
stakeholder focus groups, and develop a PSH OD Prevention Toolkit to guide implementation. In this
preparation phase we will adapt an existing package of EBPs in consideration of the unique environmental
characteristics of PSH and will prepare for implementation. Aim 2 is to evaluate implementation of evidence-
based OD prevention practices across diverse PSH buildings and effectiveness on PSH tenant outcomes in a
stepped wedge trial. In this Hybrid Type 3 effectiveness-implementation study, the primary implementation
outcome is PSH building adoption of the OD prevention EBPs. We will additionally examine secondary
implementation outcomes, tenant clinical outcomes, and implementation sustainment. Aim 3 is to explore
multilevel factors influencing implementation—including barriers and facilitators—and refine dissemination and
implementation frameworks for housing settings, using qualitative interviews with PSH staff. The research
draws from the EPIS (Exploration, Preparation, Implementation, Sustainment) implementation framework and
Rhodes’ Risk Environment Framework. The research will inform implementation frameworks and strategies by
examining application of EPIS for PSH and testing novel housing-relevant implementation strategies including
staff-tenant implementation champion dyads. Findings from this PSH-focused research are expected to be
more broadly applicable to other types of housing and settings serving people experiencing homelessness.
The multidisciplinary investigator team will work with a Stakeholder Advisory Board to maximize impact of the
research, which has been designed to inform local and national programmatic and policy interventions.
Changes in the epidemiology of the U.S. OD crisis highlight the need for concerted efforts to reduce the
disparate burden of ODs faced by particularly marginalized populations.

Public health relevance
PROJECT NARRATIVE As the face of the overdose crisis changes, focused attention on marginalized populations and the social conditions affecting overdose is critically important to forestall deaths and reduce widening inequities. The proposed study uses a stepped wedge cluster randomized controlled trial and qualitative interviews to examine the implementation of evidence based practices to prevent overdose in permanent supportive housing— housing that serves formerly homeless individuals who face disproportionately high risk for overdose—in New York City and New York’s Capital Region. Findings will lay the groundwork for widespread implementation of overdose prevention practices in permanent supportive housing, as well as inform similar implementation efforts for other housing settings that serve at-risk populations.